Development of novel therapeutics for opioid dependence

PROJECT SUMMARY
This application is submitted in response to RFA-DA-19-002, Development of Medications to Prevent and Treat
Opioid Use Disorders and Overdose (UG3/UH3). The application describes a highly integrated project aimed at
developing novel Gpr151 antagonists to facilitate long-term abstinence in opioid-dependent individuals. Gpr151
is an orphan G-protein coupled receptor (GPCR) that is expressed almost exclusively in the medial habenula. In
exciting new data, we demonstrate that Gpr151 co-localizes with μ opioid receptors in the medial habenula and
that this orphan receptor regulates the inhibitory effects of opioids on habenular neurons. Moreover, we show
that Gpr151 plays a critical role in regulating the motivational properties of opioid drugs such as morphine and
oxycodone in mice. Specifically, we find mice with null mutation in Gpr151 (Gpr151-/- mice) are resistant to the
stimulant and rewarding effects of these opioids and self-administer lower quantities of oxycodone. Here, we
propose to leverage this new knowledge, in conjunction with our expertise in small molecule drug development,
to identify and optimize novel Gpr151 antagonists for the treatment of opioid dependence in humans. As Gpr151
is an orphan receptor for which there are no known ligands, the lack of potent agonists can hamper the
identification of novel antagonists. However, we have now developed robust cell-based assays (and appropriate
counter-screens) to reliably monitor Gpr151 function and used these assays to identify novel Gpr151 agonists.
During the UG3 phase of this application, we will optimize this series of agonists to increase their potency and
selectivity for Gpr151 (12 months). Once optimized, we will use potent and selective agonists from this series to
facilitate the identification of novel antagonists at Gpr151 derived from the same or related chemical series
(primary strategy) or via high-throughput screening (backup strategy) (12 months). Identification of novel Gpr151
antagonists will trigger the transition to the UH3 phase of the project. During the UH3 phase, we will employ an
iterative medicinal chemistry based on structure-activity relationships (SAR) to optimize the potency and
selectivity of novel Gpr151 receptor antagonists. SAR will also be used to optimize these antagonists for drug
metabolism and pharmacokinetics (DMPK) and brain penetration properties, and identify those that are least
likely to have toxicity in humans. We will assess the effects of those with the most favorable drug-like
physiochemical properties on electrophysiological responses of medial habenula to opioid drugs. In addition, we
will assess the in vivo efficacy these novel antagonists using the intravenous oxycodone self-administration and
reinstatement of extinguished responding procedures in wild-type and Gpr151-/- mice. This multidisciplinary
research plan will capitalize on the unique relevant scientific and drug discovery expertise of our team of
committed investigators to develop novel therapeutics to facilitate abstinence in opioid-dependent individuals.

Public health relevance
PROJECT NARRATIVE Opioid dependence is a leading cause of premature death and disease in the United States. We have shown that Gpr151 is enriched in the medial habenula where is plays a critical role in regulating the motivational properties of opioid drugs. In this application, Here, we propose to develop Gpr151 antagonists as novel medications to facilitate long-term abstinence from opioid use in those suffering from opioid use disorder. If successful, this program of drug development promises to have a significant positive impact on human health.